Training for Scientists Conducting Research to Reduce HIV/AIDS Health Disparities

ABSTRACT
This application seeks continuation of funding for the program “Training for Scientists Conducting Research to
Reduce HIV/AIDS Health Disparities” at the University of California San Francisco (UCSF). This program
addresses the urgent need to reduce HIV-related health disparities in the marginalized communities most
affected by HIV. Our training program provides education and mentoring to early-career social and behavioral
HIV researchers (hereafter Visiting Professors or VPs) who have demonstrated cultural expertise, a
commitment to improving the health of communities affected by HIV, and are initiating innovative programs of
research to advance the objectives of the Office of AIDS Research Annual Strategic Plan and program
priorities of the NIMH Division of AIDS Research (DAR). The aims of this five-year project are to: 1) Support
VPs in refining innovative ideas, concepts, and theories into clearly articulated and feasible HIV health
disparities research with marginalized communities in line with NIMH/DAR priorities; 2) Fund an individualized
applied research experience (ARE) to strengthen VPs' research capacity to disseminate results, which will
accelerate their career trajectories and be used in NIH grant proposals; 3) Provide education, mentoring and
technical assistance to VPs in the conceptualization, writing, submission, revision, and resubmission of NIH
research proposals through use of an individual development plan (IDP), mentoring meetings, seminars,
webinars, and peer networking; and 4) Provide ongoing individualized technical assistance and mentoring
focused on research and career development through writing retreats and peer reviews to VPs who have
completed the program. We will accomplish these aims through a research education and mentoring program
at UCSF's Center for AIDS Prevention Studies (CAPS). The centerpiece of the proposed program is a summer
training institute in which visiting professors, who have not yet obtained R01-level funding, participate in an
intensive program over a three-year period. Each visiting professor is in residence at CAPS for six weeks for
three consecutive summers. In the first summer, the program helps visiting professors develop their ideas into
feasible programs of research and design and implement an applied research experience funded by the
program. During the second summer VPs begin an NIH grant proposal. Following the second summer, they
finalize their grant proposal and submit it to NIH. In the third summer, they revise and resubmit their proposals
to NIH. The activities are additionally enhanced through webinars and meetings with faculty mentors scheduled
during the academic year. Alumni receive additional support to remain in the HIV research pipeline through
alumni peer reviews, writing retreats, and participation as alumni mentors in the summer institutes. The
proposed program is well positioned to leverage CAPS' unique environment to provide tailored research
education and mentoring in social/behavioral HIV research, assist program participants to become successful
independent investigators, and simultaneously increase the diversity of HIV scientists.

Public health relevance
PROJECT NARRATIVE Research to advance understanding of the development and progression of diseases and disabilities that contribute to health disparities is a major goal of the National Institutes of Health's strategic research plan to reduce and ultimately eliminate health disparities. The proposed five-year program aims to address this public health need by providing research education and mentoring to early-career social and behavioral HIV researchers who have demonstrated cultural expertise, a commitment to improving the health of marginalized communities affected by HIV, and are initiating innovative programs of research to advance the program priorities of the NIMH Division of AIDS Research. The core of the program is: an innovative, intensive six-week summer in-residence program of seminars and peer reviews; one-on-one consultations with mentors; research experience funding; ongoing support from mentors and webinars during the academic year; and writing retreats and peer reviews for VP alumni to support them in submitting new NIH grant proposals and remaining in the research pipeline.